Investigating a Newly Discovered Aspect of Dopamine Signaling

PROJECT SUMMARY/ABSTRACT
This proposal emerges from the discovery that the D1 family of dopamine receptors, a class of G protein
coupled receptor (GPCR), long considered to only signal from the plasma membrane, also signal from
the Golgi membranes. This subcellular and compartmentalized signaling challenges some of the basic
paradigms of signaling regulation. D1 dopamine receptors are the main GPCR in the midbrain and
regulate functions such as locomotion, cognition, attention and impulse control. Several pathological
conditions including Parkinson's disease, schizophrenia and addiction are due to dysregulation of this
signaling pathway. Many drugs of abuse promote dopaminergic transmission within the midbrain by
increasing the release of dopamine and activating D1 dopamine receptors, D1DRs. This increased
activity of midbrain dopaminergic neurons results in increased locomotor activity and motivational
behaviors such as craving and drug-seeking. In all of these studies, it has been assumed that functions
of D1DRs are mostly limited to the plasma membrane. Our data challenge this assumption. We show
that these receptors signal from both the plasma membrane and the Golgi in the midbrain neurons
relevant to locomotor and motivational effects regulated by dopamine. We have found that signaling from
each compartment has distinct effects on the molecular and cellular consequences of D1DR activation.
Importantly, we have found that D1DR signaling from the Golgi plays a critical role in the molecular
mechanisms associated with dopaminergic signaling events related to addictive behaviors.
The overall goals of this proposal are to elucidate the molecular, cellular and physiological
consequences of D1DR signaling from the PM and the Golgi compartments in primary medium spiny
neurons, MSNs. We have developed or adapted state-of-the-art tools such as a light-controlled nanobody
recruitment system and photoactivatable bacterial adenylyl cyclase to selectively modulate D1DR
signaling at a given subcellular location. We will combine these tools with molecular and cellular readouts
of neuronal activity as well as a high throughput phosphoproteomics approaches to identify the
consequences of signaling from each compartment. We will then apply these tools in zebrafish, an
established animal model to study the significance of D1DR compartmentalized signaling in regulating
dopaminergic-mediated behavior. This project brings together conceptually and technically innovative
approaches in cells and in intact animals as well as high throughput methods to identify downstream
targets and potentially new therapeutic targets for countering the effects of mis-regulation of
dopaminergic signaling.

Public health relevance
Project Narrative Addiction kills thousands of Americans every year. Understanding cellular mechanisms controlling brain's reward system will help to further develop or improve therapies for substance use disorders. Thus, identifying new molecules that regulate brain function will provide new insight into regulation of brain in health and in pathological condition such as addiction.